THE VAGINAL MICROBIOME, MATERNAL RESPONSE, AND PRETERM BIRTH

ABSTRACT
An estimated 13 million preterm births (PTBs) occur annually worldwide, and PTB is the single most
significant contributing factor to neonatal morbidity and mortality. Mechanisms underlying preterm
birth are unknown hampering development of effective prediction and prevention strategies. PTB is
linked to local and distant infections and recent data suggests that vaginal bacterial microbiome early
in pregnancy is associated with subsequent preterm birth. Viral infections behave differently during
pregnancy, with common viral infections such as varicella and influenza causing much more severe
disease during pregnancy and human papillomavirus, the causative virus in cervical cancer,
associated with a 2-fold increased risk for PTB. However, comprehensive assessment of vaginal viral
communities during pregnancy has not been performed. Lastly, although maternal inflammation is
one of the leading triggers for PTB the precise constellation of inflammatory signals is not known. We
propose that examining microbial communities or host response alone is incomplete, but that their
combination will lead to refined definitions of appropriate and inappropriate microbe-maternal biology
and shed new light on the old problem of PTB.
Our central hypothesis is that preterm birth can be estimated by a combination of three criteria:
vaginal bacterial communities, vaginal eukaryotic viral communities, and maternal
inflammatory response. We have an interdisciplinary team assembled including perinatologists,
epidemiologists, virologists, and genomics informatics experts, leveraging the unique capabilities of
the McDonnell Genome Institute at Washington University in St. Louis, a well-established pregnancy
bio-specimen and clinical data infrastructure, and a high-PTB burdened racially diverse patient
population to test this novel hypothesis.
The aims of this project are: 1) Determine the ability of bacterial and viral communities in the vagina
and their dynamics over time to predict preterm birth 2) Determine the ability of the host inflammatory
response in the vagina in the context of microbial communities to predict preterm birth. The proposed
research is innovative, for the first time, comprehensively characterizing the eukaryotic vaginal virome
simultaneously with vaginal bacterial communities and longitudinally capturing the maternal response
to these communities. We employ an efficient study design, a well-established research
infrastructure, and renowned genome sequencing expertise to test a physiologically plausible but
uninvestigated paradigm that bacterial and viral communities in concert with the maternal host
response can predict PTB.

Public health relevance
PROJECT NARRATIVE—RELEVANCE TO PUBLIC HEALTH STATEMENT Over 400,000 infants are born preterm in the United States each year, adding millions of dollars to health care costs and life-long consequences for survivors and families. Recent studies show that specific bacterial communities that can be detected early in pregnancy are associated with preterm birth. Although pregnancy alters viral infection dynamics, the influence of vaginal viral communities on preterm birth has not been investigated. We plan to analyze the comprehensive vaginal bacterial and viral communities longitudinally over pregnancy simultaneously with the maternal host response in women who deliver preterm compared with those who deliver at term. We hypothesize that defining microbial communities or host response alone is incomplete, but the combination will help outline definitions of appropriate and inappropriate maternal-microbe biology, and will shed new light on the old problem of PTB. Completion of this project will lead to more refined prediction of preterm birth informing new strategies to identify women at risk and the ability to design better prevention measures to reduce this devastating and costly pregnancy complication.